Pathways to Health from Adolescence through Young Adulthood

Project Summary/Abstract
Several important studies have contributed to our understanding of the factors and mechanisms by which
experiences, behaviors, and traits in adolescence and emerging adulthood forecast the capacity to be a
competent parent and raise a healthy, prosocial child. We propose to build on this work by leveraging a large,
longitudinal intervention study (PROSPER) to: (AIM 1) Assess a developmental model that links key
adolescent risk and protective factors to three critical factors in emerging adulthood (relationship competence,
mental health, and risky behavior including substance use). These emerging adult factors, measured at ages
19–22, are in turn hypothesized to predict the quality of the early childrearing environment, measured at ages
24–28. Finally, we trace these pathways forward to estimate the unique, relative, and combined influences of
these adolescent-to-young-adulthood pathways on key domains of child adjustment. (AIM 2) Evaluate, with the
model developed in AIM 1, whether previously demonstrated intervention effects on adolescents’ family
relationships, peer network dynamics, and risky behaviors (substance use and conduct problems) in this
sample lead to impact during the family formation period on the childrearing environment and early childhood
adjustment.
To pursue these aims, we will conduct home visits across three years with 350 young adult parents (and
their families) whom we have followed since 6th grade in a randomized trial of PROSPER. The results of this
project will yield insights into the adolescent and emerging adulthood factors that can be targeted to improve
childrearing environments, as well as yield new information on the contribution of adolescent-focused
substance use prevention to the adjustment and health of the next generation.

Public health relevance
Project Narrative/Public Health Statement We propose to leverage a large, longitudinal intervention study (PROSPER) to assess the relative influence of key adolescent/emerging adulthood developmental pathways that predict the quality of childrearing environments provided by PROSPER participants in young adulthood. By testing multiple pathways, this project will yield new insights into the key adolescent and emerging adulthood factors that can be targeted to improve childrearing environments for the next generation; contribute new knowledge about the scope of effects of prevention with novel implications for cost-benefit analyses; and expand the domain of costs/benefits included in analyses of prevention from a focus solely on program participants’ own life trajectories to include costs/benefits associated with future childrearing factors and the adjustment of children in the next generation.